Investigating the mechanism of ClpX-mediated degradation in mycobacteria

PROJECT SUMMARY AND ABSTRACT
Mycobacterium tuberculosis (Mtb), which causes the disease tuberculosis (TB), is one of the deadliest human
pathogens. This is due, in part, to its inherent resistance to several classes of antibiotics and its ability to evolve
resistance through mutations. Current treatment for TB is also lengthy and causes significant morbidity,
underscoring the need for novel antibiotics. Bacterial proteolysis targeting chimeras (bacPROTACs), which work
by targeting essential proteins for degradation by proteolytic machinery, are beginning to be explored as a new
tool for combatting TB. ClpX is an essential mycobacterial protein that is known to unfold and target numerous
proteins for degradation in other bacteria, and given its essentiality, ClpX is a promising candidate for antibiotic
PROTAC development in Mtb. Still, relatively little is known about which substrates it can target, what processes
it regulates, or why it is essential in mycobacteria. By understanding the underlying biology of ClpX, we can
develop ClpX-based bacPROTACs that target its most suitable substrates, synergize with existing antibiotics,
and exploit essential interactions to prevent the evolution of drug resistance. In Aim 1 of this proposal, I will
characterize the substrates of ClpX in vivo using quantitative proteomics and validate that ClpX directly mediates
the degradation of these proteins using in vitro degradation assays. Of the proteins modulated by ClpX in vivo
and degraded by ClpX in vitro, I will evaluate which ones can be targeted for degradation by ClpX using induced
proximity. Finally, I will use machine learning to identify protein features that predict proximity-mediated
degradation to help identify additional targets for ClpX-based bacPROTACs. In Aim 2, I will test the hypothesis
that ClpX is essential in mycobacteria because it regulates DNA replication. I will first validate the interactions
between ClpX and replication proteins using reciprocal co-immunoprecipitation. I will then test whether ClpX
mediates the degradation of its binding partners in vitro and in vivo. Finally, I will test whether these DNA
replication proteins can be targeted for degradation through induced proximity to ClpX and whether this affects
bacterial viability. Together, these experiments will help determine the role of ClpX in an essential biological
process and globally define its substrates in mycobacteria. This work will serve as an important foundation for
the future development of novel PROTAC antibiotics to treat TB.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB) is one of the deadliest infectious diseases in the world, and treatment for TB is currently lengthy and associated with significant toxicity. To aid in antibiotic discovery, the proposed research will explore how the bacteria that cause TB, M. tuberculosis, maintain protein homeostasis through the essential protease ClpX. By completing these aims, this work will lay the groundwork for new antibiotic discovery to treat TB.